Assessment of Behavioral Deficits in Minipig Model of Pediatric Concussion

Project Summary/Abstract
Traumatic brain injury (TBI) is a leading health concern for both children and adults worldwide. Similarities
between pig and human brain anatomy, development, and neuroinflammatory response have brought attention
to the domestic pig as a highly promising model animal for studying age-specific responses to mechanical
trauma. To date, I have quantified baseline behavioral data in healthy Yucatan minipigs. For the duration of the
training period, I will conduct a battery of behavioral tests to identify changes in behavior and physiology in
juvenile pigs following a closed-head impact procedure designed to model pediatric concussion. In the
postdoctoral phase, I plan to develop expertise in the development of novel neurointervention strategies in large
animal models. To facilitate transition to a lab where I will need to utilize state-of-the-art imaging techniques to
validate the efficacy of my treatments, I will use magnetic resonance imaging (MRI) as an assessment tool to
quantify changes in neural structure and function in brain-injured pigs. I will receive comprehensive training in
MRI data processing from experts in both human and pig neuroradiology. The proposed training plan is
specifically crafted to prepare me, Alesa Netzley, for a fulfilling and distinguished career as a large animal
systems and translational neuroscientist.

Public health relevance
Project Narrative Due to the similarities between pig and human brain anatomy, development, and neuroinflammatory response, pigs are a highly promising model for studying age-specific responses to mechanical trauma. Here we have developed a training plan where I will use a battery of multiparametric behavioral and physiological assessments to characterize post-injury changes in a pig model of pediatric concussion. The findings from these studies could encourage researchers to use the pig to develop novel therapies for use in neurotrauma patients, and ultimately improve diagnostics and prognostication on the front lines of TBI patient care.